PROFESSIONAL ONCOLOGY EDUCATION PROGRAM

The objectives of this program are to: 1) Expand the teaching/learning experiences of medical, nursing, and graduate students, resident physicians, and practicing health care providers in the basic concepts of oncology and in the clinical management of cancer patients. 2) Encourage interdisciplinary education in the field of oncology by developing better interdepartmental cooperation in clinical and basic research programs. 3) Improve the education of all medical students and graduate nursing students in the problems of cancer by increasing their exposure to individuals within the medical school and nursing school having specialty training in cancer and related problems. 4) Improve detection and long-term management of cancer patients by educating research and clinical health care providers who will be knowledgeable in the field of oncology and able to provide proper care for the cancer patient and support for the effort to solve the problems of cancer.